Making Oligonucleotides Better Biopharmaceuticals by Steric Protection

Project Summary/Abstract
Oligonucleotides face several biopharmaceutical difficulties, including stability and delivery issues as well
as non-hybridization activities such as coagulopathy and unwanted activation of the immune system. We
have developed a unique oligonucleotide delivery system, termed pacDNA, which uses a high-density
bottlebrush polymer to provide oligonucleotides with binding selectivity. The polymer amounts to an
entropic barrier, reducing access to the oligonucleotide by various proteins (and thus side effects) but still
allows for unhindered hybridization. This novel strategy not only improves nuclease stability, preserves
target-binding capability, and minimizes off-target side effects, but also massively enhances plasma
pharmacokinetics, tissue retention, and antisense potency in vivo. Our current studies also reveal that the
pacDNA’s pharmacological properties are intimately related to the bottlebrush backbone. In addition, the
pacDNA appears to be uniquely capable of evading anti-carrier adaptive immunity, which is useful for
therapies that requires long-term/frequent dosing. Finally, the pacDNA deposits into tissues and organs
that lack mature delivery technologies for, such as the skin, the skeletal muscle, and the heart. These
surprising and enabling discoveries will be the basis for investigations in the next funding period, in which
we will 1) explore the property space of the pacDNA structure using a combinatorial polymer library with
specific backbone compositions and monomer sequences; 2) probe in vivo properties of the pacDNA in
mouse and non-human primate models and how it is able to evade adaptive immunity; and 3) explore the
potential of pacDNA to create first/best-in-class therapies that take advantage of its unique strengths using
a relevant preclinical disease model (progeria). We anticipate that accomplishment of these objectives will
yield significant fundamental understanding of this class of materials and bring us much closer to clinical
evaluation of pacDNA.

Public health relevance
Project Narrative Nucleic acids exhibit inherently unfavorable biopharmaceutical properties due to specific and non-specific interactions with proteins (enzyme stability, immunostimulation, coagulopathy, etc.), which hamper their development as therapeutic agents. Herein, we will investigate a novel mechanism for nucleic acid delivery based upon entropic protection (termed pacDNA), which facilitates duplex formation but disfavors protein binding (generally the first step leading to undesirable non-hybridization side effects). We will investigate and understand the molecular parameters that give rise to the unique properties of the pacDNA, probe its in vivo characteristics in mouse and non-human primates, and demonstrate improved efficacy in preclinical models for Hutchinson-Gilford progeria syndrome over the state-of-the-art.